Longitudinal Effects of E-cigarette Use on Cardiovascular and Pulmonary Health

PROJECT SUMMARY
Electronic nicotine delivery systems (ENDS) are used by millions of Americans, however, we do not
understand their long-term health effects. Although ENDS use delivers far lower levels of carcinogens than
tobacco smoking, very little is known about whether ENDS use affects the risks of developing cardiovascular
(CV) or pulmonary diseases, two of the most highly prevalent causes of morbidity and mortality in the United
States. This research proposal will quantify the effects of long-term ENDS use on validated and novel biomarkers
of CV and pulmonary disease and how they are influenced by use heaviness, age, body weight, and co-use of
other products. This research also will shed additional light on long-term ENDS use patterns and ENDS
dependence. The importance of this study does not rest upon demonstrating adverse effects of ENDS use.
We will recruit 400 long-term, stable users of ENDS and 200 age- and gender-matched control participants
who do not use ENDS or combustible cigarettes. They will undergo comprehensive biomarker assessments over
36 months. Biomarkers assess CV and pulmonary health status and risk and include vital signs, fasting blood
samples for systemic inflammation and oxidative stress, lipids, and markers of insulin resistance and
cardiometabolic health. Arterial structure changes will be assessed using carotid ultrasound and brachial artery
flow-mediated dilation. Sympathetic nervous system activation will be assessed by heart rate variability and
arterial diameters. For pulmonary measures, we will obtain non-contrast quantitative computed tomography (CT)
images to assess air trapping and texture-based measures of inflammation. We also will perform spirometry and
measure exhaled nitric oxide. Integrated cardiopulmonary health will be assessed via treadmill stress testing.
Other measures will include exhaled carbon monoxide, real-time measures of nicotine product use, nicotine
dependence, and use of cannabis and alcohol. Biomarker status over time will be compared across groups and
related to ENDS use heaviness, use of other products, and person factors (i.e., age, gender, race/ethnicity,
weight, and smoking history). We will include ~130 participants who were phenotyped from 2019-2021.
Our Primary Aim is to determine relationships between ENDS use heaviness and changes in our CV and
pulmonary biomarkers over 3 years. We will compare biomarker status across ENDS users and non-users over
time and examine associations between biomarker status and ENDS use heaviness within the ENDS user group.
Our Secondary Aim is to characterize changes in ENDS use patterns and dependence over time and to
determine how these are related to biomarker status changes and how they are influenced by the person factors
described above. Our primary and secondary CV measures are changes in carotid intima-media thickness and
grayscale median. Our primary and secondary pulmonary measures are the changes in the quantitative CT
measures of air trapping and parenchymal texture. This proposal will produce the most informative evidence to
date on how long-term ENDS use affects CV and pulmonary health and disease risk.

Public health relevance
PROJECT NARRATIVE Electronic nicotine delivery systems (ENDS) are used by millions of Americans, however we do not understand their long-term health effects. This research proposal will quantify the effects of long-term ENDS use on validated and novel biomarkers of cardiovascular and pulmonary disease and how they are influenced by use heaviness, age, body weight, and co-use of other products. The importance of this study does not rest upon demonstrating adverse effects of ENDS use and will produce the most informative evidence to date on how long-term ENDS use affects cardiovascular and pulmonary health.